Socioeconomic Status, Mortality, and Morbidity in Older Americans

OTHER PROJECT INFORMATION – Project Summary/Abstract
Socioeconomic Status, Mortality, and Morbidity in Older Americans
It is now well documented that the midlife mortality declines experienced in other wealthy countries over the
last 20 years have bypassed US white non-Hispanics (WNHs). For all five-year age groups from 25-29 to 50-
54, mortality rates for WNHs were higher in 2015 than in 1999, but lower for black non-Hispanics and
Hispanics. This stalling and reversal of progress is largely driven by the increasing deaths of white non-
Hispanics without a four-year college degree. Deaths from drug overdose, suicide, and alcohol-related liver
disease (“deaths of despair”) rose over this period, while progress against heart disease stalled. What is not
well understood is the causes of these differential trends. Using data on mortality, morbidity, labor market
conditions, credit scores, and social connection, our proposed research will analyze why these alarming trends
in early mortality and opioid use have occurred. We will explore multiple causal explanations, channeling
through education, employment opportunities, inequality, health behaviors, and health care. What role does
education play in rising “deaths of despair”? To what degree does deterioration in the quality and availability of
low-skilled jobs cumulatively impact mortality and morbidity over the life course? Does the success of the
highly educated come at the expense of those with less education? To what degree are disparities
accentuated by health behaviors and health care, such as opioid prescribing and treatment of cardiovascular
conditions? These various potential causal pathways are not mutually exclusive, but establishing their
importance is critical to developing meaningful interventions, whether in education, labor markets, health care,
social supports, or other policies. And finally, we will consider whether the adverse mortality and morbidity
patterns evident in midlife, are likely to carry forward into older ages, or to revert to the more favorable patterns
currently experienced by the elderly.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative This project seeks to understand the alarming health declines among some populations in mid-life, as reflected in rising mortality, drug overdose, suicide, alcohol-related liver disease, and other aspects of health. The project explores multiple causal explanations, channeling through education, employment opportunities, inequality, health behaviors, and health care. Assessing these various causal pathways is critical to developing meaningful interventions, and to extrapolating future health trends, as these midlife populations advance into old age.